Pathologic Substrates of Neuropsychiatric Symptoms in Aphasic Dementia

PROJECT SUMMARY. The increasing prevalence of dementia worldwide is considered a looming public health
crisis, and few effective treatments are available to alleviate patients’ cognitive decline and associated psychiatric
symptoms. Primary progressive aphasia (PPA) is a clinical dementia syndrome defined as an initial, focal decline
in language abilities and atrophy of the language-dominant hemisphere. While not a core diagnostic criterion,
most persons with PPA also develop severe neuropsychiatric symptoms, such as apathy and disinhibition, which
are distressing and burdensome to both patients and their caregivers. Determining the biological substrates of
these symptoms is challenging because one dementia syndrome can result from several underlying pathologies.
In PPA, for example, underlying neuropathologies include Alzheimer’s disease (AD) and frontotemporal lobar
degeneration with tauopathy (FTLD-tau) or TAR DNA-binding protein 43 (FTLD-TDP). The exact biological
substrates causing neuropsychiatric symptoms to emerge and worsen over time in dementia syndromes are
unclear. Understanding how regional distributions of various pathologies lead to neuropsychiatric presentations
may serve as a valuable antemortem biomarker and deepen our knowledge of brain-behavior relationships. A
central hypothesis is that each pathology will be associated with distinct neuropsychiatric signatures that change
predictably with disease progression. To investigate this, the proposed research will identify the neuropsychiatric
symptoms unique to AD, FTLD-tau, and FTLD-TDP within one dementia syndrome (PPA). The focus of Aim 1 of
this study is to characterize distinct neuropsychiatric phenotypes of multiple underlying pathologies as they lead
to PPA. It is hypothesized that symptoms will initially diverge between neuropathologies and will converge in the
final stages of disease. Unique and shared neuropsychiatric symptoms will be assessed longitudinally between
AD, FTLD-tau, and FTLD-TDP in PPA relative to each other and to a cognitively healthy group. The goal of Aim
2 is to determine relationships between neuropsychiatric signatures and pathologic markers in frontal and limbic
brain regions. It is expected that hemispheric and regional densities of different these markers will show strong
associations with salient neuropsychiatric symptoms. Bilateral frontal and limbic regions will be analyzed for
pathologic inclusions, neuronal and synaptic integrity, and neuroinflammatory (microglia) markers, which will be
quantified in whole hemisphere sections using unbiased stereology and digital pathology methods. This project
will occur within the Northwestern Alzheimer’s Disease Center, which is a multidisciplinary, international PPA
referral center that will provide access to over 50 postmortem brains from persons with PPA and thus represents
an
ideal environment for the proposed research and training. The public health impact of this study is substantial
as AD, FTLD-tau, and FTLD-TDP underlie the majority of neurodegenerative dementias, and results have the
potential to inform diagnostic and treatment approaches for patients with dementia.

Public health relevance
PROJECT NARRATIVE Dementia diagnoses are projected to rise exponentially in the next several decades, with the vast majority of patients developing neuropsychiatric symptoms that are burdensome and difficult to treat. One of the most challenging aspects of identifying the biological substrates contributing to symptoms in dementia is that one dementia syndrome can be caused by different postmortem pathologies. This study will examine associations between anatomic distributions of pathology and neuropsychiatric symptoms in primary progressive aphasia— a language-based dementia caused by multiple pathologies—with the goal of uncovering the putative substrates of neurodegeneration that may enhance diagnostic accuracy, predictions of future decline, and treatment approaches.